Novel SMARD1 Mouse Models: Characterization and Evaluation of Potential Therapeutic Targets

Abstract
When motor neurons degenerate, they lose their ability to communicate with their downstream muscle targets and, as a
result, muscles weaken, often leading to paralysis and death. This commonality is shared between rare diseases such as
Spinal Muscular Atrophy, Amyotrophic Lateral Sclerosis, and SMA with Respiratory Distress Type I (SMARD1).
Collectively “rare” disorders are strikingly common, afflicting ~30 million people in the United States alone. Understanding
commonalties between these different conditions not only leverages disease-specific research but also provides
opportunities to exploit shared biochemical pathways for therapeutic development. With this as a backdrop, this project
focuses on the IGHMBP2 gene, that when mutated results in a severe motor neuron degenerative disease, SMARD1;
mutations in IGHMBP2 are also found in a subset of CMT2 (Charcot-Marie-Tooth Type2) patients. IGHMBP2 is a
ubiquitously expressed protein with helicase function and proposed roles in RNA regulation or RNA metabolism.
SMARD1 is an autosomal recessive motor neuron disease that primarily affects children, with a life expectancy of ~13
months. The prevalence of SMARD1 is ~1 percent of early onset SMA patients. SMARD1 is initially characterized by distal
lower limb muscle atrophy with proximal muscle weakness later. The first major SMARD1 clinical symptom, respiratory
complication, is due to diaphragmatic paralysis. We have recently generated four unpublished mouse models with mutations
in Ighmbp2 that correlate to mutations within the SMARD1 patient population. The objective of this project is to characterize
two of the new models with Ighmbp2 mutations C495X and D564N. C495X correlates to the patient C496X mutation that
is the most prevalent IGHMBP2 mutation identified in SMARD1 and is also found in some CMT2 patients. C495X is found
as a homozygous recessive mutation and as a compound heterozygous mutation in patients and presents with respiratory
distress and motor neuron defects as early as days and as late as years. D564N correlates to the patient D565N mutation and
has only been identified as a compound heterozygous mutation with clinical symptoms initiating as early as several months
of age. D565N protein binds nucleic acid, has ATPase activity, but lacks helicase activity.
Experiments in AIM I are designed to address: disease onset, disease severity, and the relationship between the type of
mutation and SMARD1 symptoms. In AIM II we will examine the molecular and cellular phenotypes, including RNA and
protein expression, motor neuron and muscle analyses, and respiratory function. These data will be compared to studies that
have examined the nmd mouse (the only SMARD1 model currently available) and SMA and ALS models. AIM III will
address translational approaches. These studies should provide significant information into the role of Ighmbp2 in cellular
processes and SMARD1 development. Additionally, these studies should provide a greater knowledge base to facilitate
therapeutic development and a better understanding of the similarities and differences between related neurological diseases
to more completely address therapeutic development.

Public health relevance
Project Narrative - Relevance to Public Health Spinal Muscular Atrophy with Respiratory Distress Type I (SMARD1) is a devastating neurodegenerative disease with no effective treatment or cure. This project is designed to characterize two novel SMARD1 mice models that are based on patient mutations as well as evaluate some potential therapeutic targets. The characterization of these mice will provide a valuable resource towards understanding how IGHMBP2 mutants result in SMARD1 disease development.